EGF RECEPTOR IN SMOOTH MUSCLE CELL FUNCTION

Heparin and related heparan sulfate glycosaminoglycans inhibit smooth muscle cell (SMC) proliferation and migration. This observation is of significance because heparan sulfate proteoglycans may play a role in regulating the growth state of SMCs in the normal arterial wall. Heparin inhibits SMC activation by thrombin and serum but not PDGF-BB. In preliminary experiments, we have shown that thrombin signaling is mediated in part by heparin-binding EGF-like growth factor (HB-EGF), activation of the EGF receptor (EGFR), and is not blocked by heparin. The primary objective of this research program is to test three hypotheses: 1. EGFR activation is required for SMC migration in vitro and in vivo; 2. PDGF-BB and thrombin utilize different mechanisms for EGFR transactivation; 3. EGFR activation induces the expression of heparan sulfate proteoglycans that then modulate EGFR function. We propose a combined in vitro and in vivo approach using cultured baboon and rat SMCs, the balloon-injured rat carotid artery, and pharmacological strategies for modulating HB-EGF, EGFR, PDGFR, and thrombin receptor function.